Testing a Dyadic Model of Proximal Suicide Risk in Young Adult Romantic Couples

PROJECT SUMMARY/ABSTRACT
Suicide is a leading cause of death in young adults, especially among those with borderline personality disorder
(BPD), of whom up to 10% of whom die by suicide. BPD is hallmarked by relationship threat sensitivity (e.g.,
hyperreactivity to perceived rejection) which predicts conflict in romantic relationships, and often immediately
precedes suicide-related events (SREs; suicide ideation, suicide-related communication, preparatory behaviors,
attempts). While most theories of suicide explicitly underscore the importance of relationship factors however,
suicide research has focused almost exclusively on the suicidal individual and failed to consider the dyadic
context in which the suicidal individual exists. Thus, the overarching goal of this project is to identify dyadic
interpersonal mechanisms within romantic relationships of high-suicide-risk young adults that exacerbate and
maintain suicide risk. We will test a dyadic model of suicide risk whereby multimodal indices of emotional
reactivity and problematic communication during dyadic conflict function to increase and maintain risk for SREs
over time. To achieve this goal, we will recruit 168 romantic couples (ages 18-35) in which at least one member
has had recent SREs and is thus at high risk for suicide. We will stratify the sample to ensure a full range of
relationship threat sensitivity and BPD severity, and these distal risk factors will be examined as predictors and
moderators of all hypothesized effects. Participants will complete a baseline laboratory assessment including a
laboratory-based dyadic conflict discussion task and a 14-day ecological momentary assessment (EMA) protocol
with continuous ambulatory psychophysiology and brief samples of audio recordings. Additionally, dyads will
complete three follow-up assessments of SREs and psychosocial functioning at 4-, 8- and 12-months post-
baseline. Our specific aims are to: 1) Examine interdependent associations between emotional reactivity and
problematic communication in romantic dyads with suicide risk; 2) Investigate whether within-individual and
dyadic patterns of emotional reactivity and problematic communication predict proximal increases (over hours,
days) in SREs; and 3) Assess whether emotional reactivity and problematic communication following SREs
functions to reinforce future SREs and predict worsening trajectories of suicide risk and psychosocial functioning.
Findings from this study will lead to improved assessment tools, identify novel couples-based intervention
targets, and inform the development of evidence-based strategies to reduce suicide risk and psychosocial
impairment in vulnerable individuals.

Public health relevance
PROJECT NARRATIVE Suicide is a serious public health crisis and a leading cause of death in young adults, especially among those with borderline personality disorder (BPD). Results from this study will advance understanding of dyadic interpersonal mechanisms within romantic relationships that exacerbate and maintain suicide risk in young adults, including those with and without BPD. The ultimate impact of this work is to inform improved, evidence- based assessment tools, identify new targets for intervention, and develop partner-involved intervention strategies to reduce suicide risk and improve psychosocial functioning in vulnerable young adults.